Optimizing anti-microbial immunity by targeting Sts-1

Project Summary
Recent studies have established two homologous phosphatases, Sts-1 and -2, as negative regulators of immune
signaling pathways. Interestingly, mice lacking Sts expression (Sts-/-) are profoundly resistant to infection by a
number of virulent microbial pathogens, including Candida albicans, Staphylococcus aureus, and Francisella
tularensis. Resistance is associated with rapid pathogen clearance, reduced inflammation, and increased
survival. The overall goal of this project is to develop new therapeutic strategies that promote enhanced anti-
microbial immune responses. The hypothesis to be tested is that drug-mediated inhibition of Sts phosphatase
activity will recapitulate the Sts-/- phenotype and lead to beneficial clinical outcomes. Having previously identified
high quality Sts-1 inhibitors in a large-scale HTS campaign, this work is expected to produce fully validated lead
compounds for subsequent lead optimization. This will be accomplished via three synergistic inter-related Aims:
Aim 1: Hit-to-lead optimization of Sts-1 inhibitors. Our working hypothesis is that potent, selective inhibitors
of Sts phosphatase activity with favorable ADME can serve as lead series for the development of an innate
immune checkpoint inhibitor that enhances antimicrobial immunity.
Aim 2: Elucidate Sts intracellular activities and identify promising inhibitory compounds. Our working
hypothesis is that drug-mediated inhibition of Sts will upregulate macrophage antimicrobial signaling pathways
and effector responses.
Aim 3: Role of Sts in vivo and identification of inhibitors with in vivo efficacy. Sts-/- animals are significantly
resistant to S. aureus lethal bloodstream infection. Our working hypothesis is that drug-mediated inhibition of Sts
activity will recapitulate the Sts-/- antimicrobial resistance phenotype and increase host immunity to S. aureus
infection.

Public health relevance
Project Narrative The goal of this project is to develop new therapeutic strategies that promote enhanced anti-microbial immune responses. Mice lacking expression of the Sts phosphatases are profoundly resistant to infection by a number of virulent microbial pathogens. The hypothesis to be tested is that drug-mediated inhibition of Sts-1 phosphatase activity will recapitulate the Sts-/- phenotype and lead to beneficial clinical outcomes due to the potentiation of antimicrobial immune responses.